A systematic approach to uncover the basic mechanisms of checkpoint inhibitor immune related adverse events

ABSTRACT
Immune checkpoint inhibitors (ICIs) have profoundly altered cancer treatment. However, despite this technique’s success,
there remain major challenges to ICIs use that must be met to best advance these therapies. These include increasing
responsiveness to PD-1 and CTLA-4 blockade, uncovering new targets to optimize pathway blockade and addressing why
more than one third of all patients that receive ICIs develop often devastating immune related adverse events (irAEs)
syndromes characterized by various patterns of off-target organ inflammation. There is currently no clear understanding
of the complexity and heterogeneity of irAEs and as ICIs approaches are expanded, understanding the basic mechanisms
of irAEs stands to be a critical goal. We hypothesize that three distinguishable, but not mutually exclusive, pathogenic
processes drive irAEs, and that the contribution of each varies according to the type of the irAEs. The first process is not
tumor-related and is predetermined by known T cell autoimmune susceptibility genes, reflecting a failure of the negative
selection mechanism. However, progression to an autoimmune disease is held in a latent preclinical stage by peripheral
tolerance mechanisms until triggered by the inhibition of these mechanisms through ICIs. We hypothesize that the second
process driving irAEs is an intrinsic consequence of the T cell immune response directed to tumor antigens. We envision
that some of the TCR clonotypes responding directly to the tumor are specific for a peptide that is also expressed by target
organ MHC molecules involved in the irAEs, and that activation of this expanded clone by ICIs initiates its attack on the
tumor and on the target tissue, resulting in irAEs. Finally, since many of the tumor-infiltrating lymphocytes are not clonal,
we hypothesize a third process of irAEs wherein the inflammatory response is mediated by promiscuous nonspecific TCR
clones activated by ICIs or the tumor inflammatory milieu. Aim 1. To characterize the human T cell repertoire of irAEs
patients. We will perform a gDNA repertoire analysis and single cell TCR seq of T cells isolated from the blood, synovial
fluid, and synovial tissue of patients with irAEs, to uncover the physical-chemical properties of CDR3s in comparison to T
cells that mediate other autoimmune diseases. We will take advantage of the gDNA to test the hypothesis that the
entrance of these self-reactive TCRs in a patient’s repertoire is influenced by the variants of the same non-HLA alleles
associated with other autoimmune disease susceptibility and the failure of negative selection and examine the role of the
MHC allotype on repertoire selection and irAEs development. We will use humanized immune system mice to recreate,
from hemopoietic stem cells, a replica of the irAEs patients’ pre-ICIs and pre-tumor TCR repertoire, to study repertoire
evolution. Aim 2. To immunophenotype the irAEs mouse model. We developed a novel mouse model for ICIs-induced
adverse events. We will perform CITEseq of T cells isolated from tumors and inflamed organs to uncover differential
subsets of cells and their functions across different types of tumors. Through tetramer staining and TCRseq, we will
uncover the contribution of tumor-specific T cells to the pathogenesis of irAEs. We will utilize multiplex IF studies to
uncover the contribution of the tumor and the inflamed organ microenvironment to the function of the infiltrating cells.

Public health relevance
NARRATIVE The immune system could recognize and eliminate cancers; however, tumors have the capacity to evade immune elimination by generating immunosuppressive microenvironments. Recently developed immunotherapies for cancer can overcome these tumors’ evasive actions and, in some cases, have led to durable, long-term survival; however these immunotherapies may also result in mild to severe inflammatory reactions and, in some instances, life-threatening autoimmunity. This project will apply new genetic tools to define the molecular mechanisms of these unwanted inflammatory adverse events and may propose approaches that may reduce the incidence and severity of these immune relate adverse events.